A DNA origami platform for measuring membrane protein interactions

Project Summary/Abstract
Cell membranes are populated with proteins whose interactions are important for myriad cellular
functions, from metabolism to signaling, including many functions implicated in processes such
as neurodegeneration. Membrane proteins are notoriously difficult to handle and study. For many
membrane proteins it is unknown whether they exist singly (as monomers), in pairs (as dimers),
or larger collections (higher oligomers). A method to determine the number and arrangement of
subunits in a protein complex within its native lipid membrane environment would resolve a
number existing controversies, and would eventually have a large impact human health. One
approach to this problem would be to study protein interactions at the single molecule level, which
can require expensive and complex instrumentation. Another approach would be to employ a
relatively inexpensive, chemically self-assembled “molecular hand” to program the interactions
between precisely controlled numbers and ratios of proteins (their “stoichiometry”). Taking the
second approach, we propose to develop a general platform for studying protein-protein
interactions in lipid membranes, the DNA origami ring-templated liposome. This platform will
allow exquisite control and measurement of protein-protein interactions within a single lipid
bilayer, and overcome the limitations of existing methods for differentiating monomers from
dimers. A DNA origami ring, filled with a disc-shaped liposomal membrane, will be constructed
with attachment points for individual proteins of interest. Spaced with nanometer-precision along
the edge of the ring, these attachment points will be used to define the number and type of protein
subunits that can enter the membrane. Programmed release of the proteins into the membrane
will be achieved through the introduction of DNA signals, that break DNA linkers between the
proteins and the edge of the DNA ring. In our first aim, we will prototype and troubleshoot the
platform by studying the interactions of fluorescently labelled DNA test molecules in a number of
control experiments. In a second aim, we will replace the DNA test molecules with proteins having
a known interaction, and verify that the platform can be used to measure protein-protein
interactions. In a final aim, we will focus on resolving a long-standing question regarding the
dimerization of a SNARE complex protein Synaptobrevin 2, which is an important participant in
the membrane fusion process required for the release of neurotransmitters.

Public health relevance
Project Narrative The structure of membrane protein complexes is fundamental to our understanding of phenomena ranging from the transmission of neuronal signals to the immune response, and thus ultimately bears on everything from models of neurodegeneration to the design of drugs for a wide variety of illnesses. The detailed arrangement of subunits in many membrane protein complexes has been difficult to determine. Our aim is to develop a new tool that will allow exact numbers of proteins to be released into an isolated patch of membrane, enabling the number and nature of protein-protein interactions in membrane protein complexes to be determined.